Wearable multifunctional optical device for early detection of postpartum hemorrhage

Project Summary
In this K99/R00 Pathway to Independence application, Dr. Christine O’Brien proposes detailed training
in optoelectronics and postpartum hemorrhage physiology that will strategically complement her expertise in the
development of optical diagnostics for women’s health. The training plan is paired with scientific studies that will
develop and utilize a novel multifunctional optical device for early detection of postpartum hemorrhage in
pregnant patients. The primary goal of Dr. O’Brien is to become an independent researcher in women’s
health technologies. The rigorous training described and the outstanding team of mentors in wearable optical
devices (Drs. Achilefu and Culver) and translational maternal health research (Drs. England and Stout) will
ensure her success in reaching this ambitious goal. Through her training plan, Dr. O’Brien will gain 1) expertise
in development of small, portable optoelectronic devices; 2) strengthened knowledge of postpartum hemorrhage
physiology and research; and 3) knowledge of strategies and best practices for running a successful and
innovative independent lab.
Postpartum hemorrhage (PPH), defined as the loss of 1 L of blood or more within 24 hours after birth, is
the leading cause of maternal mortality worldwide. Importantly, PPH is the most preventable cause of maternal
mortality, and the leading factors causing preventable PPH are delay in diagnosis and treatment. Thus, there is
an urgent need for an early and accurate alert system that can facilitate prompt treatment to prevent PPH-related
mo. During hemorrhage, the body tries to compensate for blood loss by shunting blood from the periphery to
vital organs and replenishing reduced blood volume with water from the interstitium. These compensation
mechanisms help stabilize the patient, delaying the time until global vascular indicators such as blood pressure
and heart rate are affected, the current measurements used to predict PPH. Thus, monitoring of peripheral blood
flow and blood content can yield early indicators of hemorrhage. Optical technologies are well suited to
noninvasively measure blood flow and blood content. Preliminary experiments run by the candidate
demonstrated sensitivity to reduced perfusion in vivo and measured significant differences between blood
samples diluted to physiologic levels seen during PPH using complimentary optical approaches. Based on this
preliminary data, she hypothesizes that early changes in peripheral blood flow and water transfer from
interstitium to the vasculature will be detected using wearable optical techniques, and such changes can detect
early stages of PPH. The applicant proposes to develop a multifunctional wearable optical device to measure
these early responses towards the development of an early warning system for improved PPH management.

Public health relevance
Project Narrative Postpartum hemorrhage, the loss of one liter of blood or more within 24 hours after birth, is the leading cause of maternal death despite being largely preventable with early diagnosis and treatment. Although not currently monitored, immediate physiologic changes help stabilize the patient and likely provide an early window of opportunity for treatment at early stages of hemorrhage when simple treatments are most effective. The goal of this proposal is to develop a new wearable light-based device that accurately detects early changes associated with postpartum hemorrhage thereby facilitating improved maternal health outcomes with early treatment.